MenoBrain: A Longitudinal Investigation of Menopause and Brain Health

All women who live into midlife will transition through the menopause, a critical midlife reproductive transition
accompanied by widespread physiologic change. Cohort studies have provided a broad view of changes in
women’s health occurring over the menopause transition, including declines in memory. However, knowledge
of the neurobiological basis for these changes is limited. These gaps in knowledge are due largely to the lack
of targeted, mechanistically-rigorous longitudinal studies of women’s brain health during the menopause
transition, particularly during the perimenopause, the most dynamic phase of the transition. Addressing this
gap is a major priority: It is during the perimenopause that women show the major changes in sex hormones,
increases in menopausal symptoms such as vasomotor symptoms (VMS) and sleep problems, deteriorations
in cardiovascular health, and declines in memory performance. Critically, studies of sex differences in
Alzheimer’s disease (AD) frequently implicate menopause as a key contributing factor, while acknowledging
the lack of rigorous studies to support those claims. To address these gaps, building on our related studies in
the postmenopause, we will recruit 224 women in the late reproductive to early menopausal transition (i.e.,
perimenopause) stage for two assessments over a 5-year period. At each assessment, we will conduct
comprehensive assessments of brain structure and function, cognition, cardiovascular health, sex hormones,
and menopausal symptoms (VMS, sleep) using state of the art 7T brain magnetic resonance imaging,
peripheral vascular ultrasound imaging, mass spectrometry assessments of sex hormones, and wearable
objective sleep and VMS measurements. Our primary aim is to elucidate the brain and cognitive changes that
occur during the perimenopause, and the factors contributing to these changes. We hypothesize (a) Alterations
in whole brain and hippocampal functional connectivity at rest and during memory tasks, and decreases in
hippocampal volumes and in regional cortical thicknesses and volumes; (b) Decreases in cerebrovascular
health (increases in white matter hyperintensities, in perivascular space enlargement, and in vessel tortuosity,
and decreases in cerebral blood flow); and (c) Declines in verbal memory. Secondary aims will (1) Determine
the role of menopausal symptoms (VMS, sleep changes), cardiovascular health, and sex hormones in these
changes and (2) Test a modifying role of APOE ɛ4 genotype. This work has high public health significance, as
midlife is a key window for preventive efforts to forestall adverse cognitive and brain outcomes with aging,
including AD, which has no cure and disproportionately affects women.

Public health relevance
The menopause is a universal experience for women, and many women experience memory problems during this important time of life. We aim to determine how the brain changes with the menopause and clarify how changes in hormones, cardiovascular health, and menopausal symptoms influence these brain changes. With this new knowledge, we can better help women to optimize their memory and brain health as they age so that they are more resilient to Alzheimer’s disease.